2023 Bacterial Cell Biology and Development GRC

Project Summary
The inaugural Gordon Research Conference (GRC) on Bacterial Cell Biology and Development (BCBD) will
be held at Southern New Hampshire University in Manchester, NH on June 4-9, 2023. This conference will
encompass the newest advances in understanding essential cell biological processes in a diversity of
bacteria, including human pathogens, residents of the microbiota, and organisms relevant to antibacterial
therapies. Research areas to be discussed include processes that represent well-validated targets for the
development of new antimicrobial drugs such as cell biology of envelope biogenesis, cell division, and DNA
replication and segregation. Other session topics focus on mechanisms central to bacterial replication,
survival during stress, and pathogenesis, including signaling, cellular organization and structure, cellular
decision-making, and motility. The conference will also include a themed session in the emerging area of
cell biology of interspecies interactions, including presentations on predatory bacteria and residents of the
mammalian gut microbiota. We aim to include and stimulate interdisciplinary research by bringing
together geneticists, biochemists, cell biologists, bacteriologists, structural biologists, imaging specialists,
physicists, and computational modelers who are at the forefront of developing and implementing
technologies that push our understanding of bacterial cell biology and development forward. The aims of
the conference are (1) To advance the most important problems in BCBD by providing a forum for
presentation of recent research in the field by conceptual and technical leaders (2) To promote innovation
and interdisciplinary thought by including speakers and discussion leaders with diverse training,
experimental organisms, and approaches (3) To promote networking, exchange of ideas, and
collaboration by providing abundant opportunities for formal and informal interactions among attendees (4)
To promote equity and inclusion by inviting and supporting women and individuals from groups
underrepresented in science to present and interact at the GRC and (5) To facilitate inclusion and career
development of early career scientists by inviting new independent investigators, postdoctoral fellows, and
students to participate and present their research, and by facilitating their interactions with each other and
with established investigators.

Public health relevance
Project Narrative This Bacterial Cell Biology & Development conference will bring together a diverse group of researchers to present the most recent advances in understanding processes essential to bacterial replication, survival, and pathogenesis. The research presented at this conference will advance our efforts to combat bacterial infectious diseases, and the conference will promote the career development of early career researchers, women, and individuals from groups underrepresented in science.